Multi-dimensional Approach to Address Excess Weight and Pre-Diabetes Health Disparities in Young Adults

Modified Project Summary/Abstract Section

Obesity is a major risk factor for many of the preventable chronic diseases in the US and is a leading driver to rising healthcare costs. Of particular concern are young adults progressing through college as they are more prone to weight gain compared to their peers who do not attend college. This weight gain is attributed to poor nutrition and decreased physical activity which may speak to the unique resources, barriers, and facilitators to health promotion efforts in a university setting. Addressing health behaviors in the university environment is an opportunity to build resiliency, capacity and improve health literacy at a critical period in young adulthood. A comprehensive approach is essential for examining the relationships between the social environment, the community in which a person lives and works, the individuals' personal beliefs and related behaviors, and biophysiological factors that may influence the effectiveness of any efforts. Additionally, leveraging digital technologies has shown success in delivering weight management interventions. Programs report more significant effect sizes when using behavioral techniques (i.e., tailored feedback, self- monitoring) compared to education-only internet-based interventions. Thus, to increase buy-in and sustainability, there is a need to develop and evaluate weight loss interventions for young adults in limited-resourced areas using tailored and community-based strategies. To address the barriers associated with weight control in at-risk groups, studies have adapted the intensive Diabetes Prevention Program (DPP), including a trial for postpartum women. BeFAB, a novel digital postpartum weight management intervention, was designed and previously tested. The flagship BeFAB program serves overweight and obese women and is specific, tailored, easy to use, engaging, and branded as a trusted source. With support and consultation by the original BeFAB MPIs, the proposed research builds on the evidence supporting BeFAB feasibility and seeks to adapt it to a young adult population and conduct an efficacy trial.

Public health relevance
Modified Public Health Relevance Section Young adults attending universities are at an increased risk of being burdened by excess weight and related multiple negative health outcomes. The BeFAB-HBCU mHealth intervention serves overweight and obese young adults and is specific and tailored to their immediate setting and the available resources and barriers. Informed by community stakeholders, this study evaluates BeFAB-HBCU and its impact on behavior, achieving healthy weight, and physical activity.